ModRNA-based Direct Programming of Universal Donor hiPSCs into Immune Evasive Beta Cells

Project Summary
Pancreatic beta cells derived from human induced pluripotent stem cells (hiPSCs) hold the potential to
dramatically change the treatment of type 1 diabetes (T1D). To realize the therapeutic application of these
cells, however, we need to develop a robust and rapid means for generating beta cells. Here, the investigators
propose a novel paradigm for direct programming of hiPSC into beta cells via CRISPR activation of
transcription factors (TFs). These CRISPR activation effectors will be delivered into hiPSCs using modRNAs,
avoiding genomic integrations by previous viral vector approach. Furthermore, the investigators will also use
recent advances in gene editing to generate universal donor hiPSC clones, which will be used for beta cell
programming. These universal donor beta cells can be used for allogeneic transplantation without immune
rejections.
First, the investigators will investigate optimal msgRNAs for activation of pancreatic TFs in hiPSCs. Next, they
will use a multiplexed msgRNA expression system to express all msgRNAs to activate numerous msgRNAs
coupled with the dCas9 activator modRNA to study beta cell programming. In Aim 3, the investigators will
generate immune-privileged beta cells via programming of universal donor hiPSCs. Universal donor hiPSCs
will be generated by removing B2M to inhibit T cell-mediated rejection, and by overexpression of HLA-E trimer
to avoid the natural killer (NK) cell-mediated lysis of transplanted cells. The investigators will then use in vitro
and in vivo assays to characterize programmed beta cells. For in vitro experiments, the investigator will
perform glucose stimulated insulin secretion assay. For in vivo assays, the investigator will use the NRG Akita
mice to test whether programmed beta cells can reverse diabetes in vivo. The investigator will also use
humanized NSG mice to study whether programmed beta cells from universal donor hiPSCs exhibit immune
evasive properties as compared to cells generated from normal hiPSCs.

Public health relevance
Project Narrative/Public Health Statement These exploratory studies are relevant to public health. First, this project will provide proof-of-concept evidence that it is possible to generate beta cells via direct programming of stem cells for the treatment of type 1 diabetes. Secondly, the engineered universal donor stem cell-derived beta cells can be transplanted into many patients without immune rejections, which could substantially reduce cell-based therapy cost.